Functions and mechanisms underlying epigenetic regulation of neural stem cell behavior

PROJECT ABSTRACT – Project 1 N/A per PAR-14-183

Public health relevance
PROJECT NARRATIVE – Project 1 N/A per PAR-14-183